CE19-001, Injury Prevention Research Center at Emory

PROJECT SUMMARY
In Georgia, and the U.S. as a whole, Injury is the number one cause of death for persons 1-44 years of age.
The current top five injury challenges in Georgia are: Motor Vehicle Crash, Opioid Overdose, Violence
(unintentional and intentional), Falls, and Traumatic Brain Injury. The Injury Prevention Research Center at
Emory (IPRCE) brings together researchers, injury prevention practitioners, social worker, nurses, clinicians,
students, and other groups to address prevention of all of these major threats to our community.
Our center will support the Research, Education and Training, Outreach Cores that are aimed at reducing the
top five causes of injury death. IPRCE will provide significant contributions to injury prevention science through
the completion of our four core research studies which include: (1) a study that develops and applies
geospatial statistical analytic tools that use prescription drug monitoring program, death, law enforcement,
ED/hospital discharge, and other datasets to identify social contextual determinants of local rates of overdose;
(2) an organizational readiness assessment to identify the barriers and facilitators to implementing the Cardiff
Model, which is a proven efficacious violence prevention program, through trauma centers in Georgia and their
police and community partners; (3) a study to advance the field of suicide prevention for African American
adults with a history of Adverse Childhood Experiences (ACEs) by (a) identifying risk and protective factors
that influence the ACEs/suicide relationship, and by (b) rigorously testing a culturally competent, multilevel
suicide prevention intervention targeting African American adults who have previously attempted suicide; and
(4) a study to determine whether disclosure of parent/caregiver ACEs to a young child's primary care physician
accompanied by a structured conversation about the effects of these ACEs on parental and child heath can
improve child health, build parental resilience, and support positive parenting behaviors. IPRCE will also
conduct education, outreach, and dissemination activities to build bridges between science and practice. For
example, through our Outreach Core we will build capacity, ensure rapid dissemination of our core and
exploratory research and training products, and engage practitioners in Georgia and Southeast, and through
our Training and Education Core we will support goals through multi and inter-disciplinary injury prevention
training for students, practitioners and researchers.

Public health relevance
PROJECT NARRATIVE Injury is the top cause of death for persons aged 1-44. To reduce the burden of injury, our center will conduct innovative research that is aligned with CDC NCIPC priorities and that will lead to prevention of opioid overdose, falls, motor-vehicle crashes, violence, and traumatic brain injury. We will train practitioners students, and researchers to build capacity for injury prevention among these groups; and conduct innovative outreach that improves the knowledge, skills, and communication abilities of injury prevention students, practitioners, and researchers.